Multiplexed Detection of Mosquito-Borne Viruses at the Point-of-Care

Project Summary
Dengue virus (DENV), Zika virus (ZIKV), Chikungunya virus (CHIKV), and Mayaro virus (MAYV) are all
mosquito-borne RNA viruses. They are public health concerns because (1) DENV and CHIKV cause hundreds
of millions of infections each year, with significant burdens in affected areas, (2) the outbreak of ZIKV in Brazil
in 2015/2016 caused anxieties to general population due to its association with microcephaly of newborns, and
(3) MAYV emerged in Central and Southern America recently and has the potential for epidemic spread.
Because these virus infections have virtually identical clinical presentation and they often circulate
concurrently, it is important to have a point-of-care (POC) testing platform to accurately identify virus infection
for clinical management of patients, including different complications from these viruses.
According to the Centers for Disease Control and Prevention (CDC), the current methods authorized for
assessing DENV, ZIKV, and CHIKV infections include reverse transcription polymerase chain reaction (RT-
PCR) assay and enzyme-linked immunosorbent assay (ELISA). However, these assays are carried out in
laboratories, not at POC in a clinic or in an infected field. It is also important to note that virus infection can
cause asymptomatic infections, up to 80% of ZIKV patients, 50% of DENV patients, and 28% of CHIKV
patients, respectively. As a result, POC testing in the field will be more valuable for screening asymptomatic
patients and monitoring possible virus transmission than a laboratory test because only symptomatic patients
go to hospitals or clinics for seeking medical help or to be screened.
To address the need, we propose to develop a POC diagnostic platform called Valve-enabled Lysis, paper-
based RNA Enrichment, and RNA Amplification Devices (VLEAD). VLEAD will integrate sample preparation—
including virus lysis and RNA enrichment—with nucleic acid amplification for simultaneous detection of these
viruses. To achieve the goal, we aim to (1) develop multiplexed VLEAD for simultaneous detection of ZIKV,
DENV, CHIKV and MAYV; (2) optimize VLEAD using various samples and compare the suitability of the device
for urine, saliva and blood samples; and (3) validate VLEAD using clinical samples and compare VLEAD with
the benchmark methods including conventional RT-PCR.
The significance of the research lies in the following aspects. First, these mosquito-borne RNA viruses are
a public health concern. An accurate and sample-to-answer virus detection platform at POC will be useful for
clinical care and patient management. Second, a large percentage of these virus infections are asymptomatic,
thus a non-invasive POC platform would be very beneficial for screening the general population in the infected
area and monitoring virus transmission. Third, the VLEAD platform can be adapted for detecting other
pathogens of interest, with a potential to have more societal impacts.

Public health relevance
Project Relevance Statement A point-of-care (POC) testing platform capable of detecting Zika virus (ZIKV), dengue virus (DENV), chikungunya virus (CHIKV), and Mayaro virus (MAYV) infection can be useful for diagnosing symptomatic patients, screening asymptomatic public in the infected area, and monitoring possible virus transmission.